DUKE CTSI: BEST PHARMACEUTICALS FOR CHILDREN ACT (BPCA)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This supplemental award provides funds to CTSA Consortium-supported research projects for research on outcome measures in clinical and translational child health in priority areas as determined by the Best Pharmaceuticals for Children Act (BPCA) program administered by NICHD.